Development and Evaluation of Computerized Olfactory Training Program (COT) for Cognitive Decline in Early Alzheimer's Disease

ABSTRACT
We propose to evaluate and optimize the portable, home-based product – the Computerized Olfactory Training
Program (COT) – as a disease modifying intervention for prevention of progressive cognitive decline and
progressive dementia in early Alzheimer's Disease (AD). The COT uses validated neuroprotective olfactory
stimulants to intensely engage the primary and secondary olfactory cortices, with stimulation parameters that
overcome olfactory habituation, paired with computerized olfactory cognitive training tasks that synergistically
enhance the same brain regions; with the goal of increasing structural and functional resilience to AD
progression. Phase I research and development met or exceeded stated technical milestones: COT
intervention led to increased olfactory and cognitive functions 6 and 12 months later in ApoE4 carriers with mild
cognitive impairment and early dementia. Among completers of 12-month follow-up visit, COT blunted
trajectory in shrinkage of the entorhinal cortex and the hippocampus. Furthermore, the acute effects of odorant
molecules in the COT in regulating sleep disruptions and emotional reactivity adds to a potential value of COT
for treatment of behavioral dysfunctions in advanced AD. Alzheimer’s disease is a major public health crisis
both in the United States and worldwide. Hitherto, no therapeutic has demonstrated significant effectiveness in
modifying progression from early stages to advanced stages of AD. Most putative disease modifying
therapeutics targeting various steps of amyloid biosynthesis and amyloid beta (Aβ) accumulation have either
failed to reverse cognitive decline or worsened cognitive decline in Phase III clinical trials. However,
neuroscience evidence that AD pathology progresses early, over several decades in the olfactory brain
regions, before emergence of progressive, irreversible cognitive decline and dementia, as well as experimental
and clinical findings that olfactory compromise accelerates the progression of AD, provide solid premise for
targeting olfactory structure and function in the modification of AD progression. The success of use of enriched
odor environment in reducing aggregation of pathological neurofilaments in animals spurred high hopes for
translation of olfactory training (OT) into treatment of AD in humans. Unfortunately, lack of innovative
approaches to sustain olfactory engagement sufficiently to influence functional and structural plasticity in
clinical populations, hindered the translation of OT into an AD intervention. We built an innovative olfactory
treatment delivery system for home use; established a proprietary regimen of safe neuroprotective plant
odorant extracts and stimulation parameters that overcome odorant habituation in the primary olfactory cortex;
and created a synchronized App to simultaneously administer olfactory cognitive training tasks that
synergistically target the same brain regions being stimulated by the odorants. This breakthrough product, the
COT showed excellent promise in reversing cognitive decline in our Phase I SBIR. Key technical objectives of
this Phase II project are to: (1) demonstrate COT efficacy for prevention of brain atrophy and cognitive decline
in a powered randomized clinical trial of early dementia; (2) validate its safety; (3) further configure the platform
for user-friendliness, portability for home use, acceptability and marketing; and (4) explore new indications for
treating behavioral disturbances in people with moderate to advanced dementia, in an effort to reduce care-
giver burden. Upon completion of Phase II, we will be poised to expand the research to Phase III efficacy
study, or an implementation study of effectiveness in the real-world setting through commercial partnerships
developed over the course of this project. To the best of our knowledge, this will be the first evaluation of a
home-based, scalable, computerized, chemosensory-based brain stimulation for disease modification in AD.

Public health relevance
NARRATIVE The time is now to develop disease-modifying interventions to treat and prevent progressive cognitive loss in people with Mild Cognitive Impairment and early Alzheimer’s dementia, and the olfactory system, site of early AD development, offers a unique target for brain stimulatory interventions. We developed and optimized a novel home-based olfactory chemosensory stimulation program that uses a portable, programmed, device – the Computerized Olfactory Training (COT) program – to administer olfactory psychophysical tasks while patients are being stimulated repeatedly with neuroprotective olfactory stimulants, using neuroscience-guided stimulation parameters to ensure sustained activation of all primary and secondary olfactory structures; and we showed in a pilot feasibility trial that this intervention is safe, easily applicable at home by users, and it increases performance in cognitive functions, while protecting the hippocampus from progressive shrinkage. This Phase II will demonstrate effectiveness of COT in a large sample and establish pre-market information that would lead to a final optimized marketable disease modifying product.